Development of the multisensory computations underlying flavor processing

SUMMARY
Food is perceived and enjoyed through the multisensory quality of “flavor”, which involves the senses of taste
and smell, but is not easily dissociated into its components. Flavor perception has a major influence on food
choice and is thus directly linked to health. However, the underlying neural mechanisms remain mysterious.
Previous work in humans has suggested that the brain actively combines taste and smell inputs to create our
sense of flavor, and that this process depends heavily on eating experience. However, human imaging
techniques lack spatial and temporal resolution to provide a mechanistic understanding of how neural circuits
produce multisensory flavor representations. Moreover, people’s highly subjective eating history precludes a
systematic understanding of how experience drives the development of flavor processing. To overcome these
issues, the present proposal takes a unique approach to the study of flavor. Using the awake, tasting rat as an
animal model allows us to directly access to the neural computations underlying flavor processing at the cellular
level, and complete control over the individual’s flavor experience. The proposed hypotheses build directly on
our own recent findings on cross-modal flavor processing in rat olfactory cortex, as well as decades of work on
the development of multisensory computations in cortical and subcortical regions of other multisensory systems.
The project comprises a coherent series of experiments that systematically seeks to provide mechanistic
understanding of the neural circuits that integrate flavor-related sensory information. Specifically, we will answer
the following questions: 1) What are the guiding principles by which olfactory cortical circuits integrate taste and
smell inputs? To address this, we will use electrophysiological techniques to record responses from olfactory
cortical neurons to taste-smell mixtures as well as their unisensory components in awake adult rats; 2) How are
the multisensory operations performed by olfactory cortical circuits shaped by experience with specific flavors?
To address this, we will experimentally manipulate rats’ experience with specific taste-smell mixtures, and record
responses from ensembles of olfactory cortical neurons to congruent, incongruent and unexposed taste-smell
mixtures as well as their unisensory components; and 3) How does the ability to integrate cross-modal inputs
develop across the lifespan? To address this, we will track uni- and cross-modal responsiveness of olfactory
cortex in awake rats across different stages of early postnatal development; To successfully achieve these
objectives, our unique team of investigators brings together expertise in flavor processing and awake rodent
olfactory cortex physiology (PI Maier), the computational basis of multisensory interactions (Co-I Rowland), and
the development of multisensory systems (Co-I Stein).

Public health relevance
NARRATIVE Our perception and enjoyment of food is often described in terms of “flavor”, which involves the interplay between taste and aroma (smell). However, we have surprisingly little scientific insight into how the brain creates the multisensory experience of flavor. Here we take a unique approach to this issue, tracking brain activity of animals from birth to adulthood to uncover how the foods they eat shape their flavor processing system.